Knowledge-empowered Lifespan Neuroimage Analysis

The increasing availability of large-scale lifespan brain MRI data, from Fetal Tissue Annotation (FeTA),
Developing Human Connectome Project (dHCP), National Database for Autism Research (NDAR), Baby
Connectome Project (BCP), Multi-visit Advanced Pediatric (MAP) Brain Imaging Study, Autism Brain
Imaging Data Exchange (ABIDE), Human Connectome Project (HCP), Adolescent Brain Cognitive
Development (ABCD), Open Access Series of Imaging Studies (OASIS), Chinese Color Nest Project
(CCNP), UK Biobank (UKB), Alzheimer’s Disease Neuroimaging Initiative (ADNI), and Australian Imaging
Biomarkers and Lifestyle Study of Ageing (AIBL), affords unprecedented opportunities for precise charting of
lifespan brain changes from the fetus to the elderly, providing important insights into the origins and aberrant
evolving patterns of neurodevelopmental, psychiatric, and neurodegenerative disorders. However, a major
barrier is the critical lack of lifespan-dedicated computational tools/pipelines for accurate and consistent
processing and analysis of challenging lifespan brain MRIs, which suffer from age-dependent imaging artifacts
and low and dynamic tissue contrast—especially for infant and elderly brain MRIs—as well as large inter-
site data heterogeneity inherent to different imaging protocols and scanners across sites. Most existing
tools/pipelines are designed for age-specific groups, and directly applying these to lifespan data results in
inconsistent and misleading outcomes. Therefore, the overarching goal of this project is to create and
disseminate the first knowledge-empowered deep learning pipeline for accurate and consistent atlas
construction, skull stripping, artifact correction, super resolution, harmonization, tissue segmentation,
topological correction, and brain labeling of lifespan brain MRIs. Specifically, we will develop an anatomy-
guided atlas learning neural network to construct the first set of lifespan atlases with temporally consistent and
spatially detailed patterns, and subject-specific atlas with personalized prior for subsequent aims (Aim 1). Guided
by prior knowledge from Aim 1, we will develop a novel lifespan skull stripping framework (Aim 2). After skull
stripping, we will then propose a novel deep learning framework for joint artifact correction, super resolution,
harmonization, and tissue segmentation (Aim 3). We will propose an anatomically constrained topological
correction network to ensure the topological correctness of cortex and further a transformer brain labeling to
divide the cortex into anatomical/functional regions of interest (Aim 4). Finally, we will integrate our lifespan-
dedicated tools and atlases into a comprehensive software package that is conveniently executable in both local
and cloud-based environments (Aim 5). We will freely release our software, atlases, and processed lifespan
data (150,000+ scans from 50,000+ subjects) to the public.

Public health relevance
Project Narrative This project is dedicated to creating and disseminating the first lifespan-dedicated pipeline for accurate and consistent processing and analysis of large-scale multimodal lifespan brain MRIs from multiple imaging sites. We will develop novel knowledge-empowered deep learning techniques for lifespan atlas construction, skull stripping, artifact correction, super resolution, harmonization, tissue segmentation, topological correction, and brain labeling. We will freely release our developed pipeline, lifespan atlases, and our processed lifespan data (50,000+ lifespan subjects with 150,000+ scans), to the public.